Harnessing translational research to advance understanding and clinical care in antibiotic allergy

Project Summary
Antibiotic-induced delayed-type drug hypersensitivity reactions (dtDHR) are a major yet underappreciated
public health problem, occurring commonly in skin-limited form, morbilliform drug eruption (MDE), and causing
significant morbidity and mortality in severe systemic forms, Stevens-Johnson syndrome/toxic epidermal
necrolysis (SJS/TEN) and drug reaction with eosinophilia and systemic symptoms (DRESS). Antibiotic-
induced dtDHR are significantly understudied. Consequently, understanding of immunopathogenesis has
been limited, and subsequent to that, so too clinical care. The bulk of translational research in the field
focuses on effector immune cell populations, most commonly T cells, as well as the role of Human Leukocyte
Antigen (HLA) in pathogenesis. This narrow focus along with clinical knowledge gaps and research barriers
have markedly hampered progress. Herein, we propose the potentially transformative hypothesis that
some other “X-factor” is critical in driving antibiotic-induced dtDHR onset, phenotype and/or severity.
We propose three possible “X-factors”: immune dysregulation via aberrant regulatory T cell response,
concurrent active infection, and host microbiome. Any or all of which, if true, have potential to completely
shift the paradigm of disease pathogenesis. Each factor is individually hypothesized and tested in a Specific
Aim. Each Specific Aim harnesses innovative translational approaches across humans and mice to explore
then directly test through highly mechanistic experimentation each hypothesis. There are two overarching
experimental approaches common to all three aims. First, we perform a prospective longitudinal translational
study of antibiotic-induced dtDHR patients along with matched antibiotic-tolerant controls, in which biologic
samples along with comprehensive and unbiased clinical data are collected. This overcomes several
knowledge gaps in the field and markedly strengthens the robustness and clinical applicability of our
translational findings. Second, we exploit our own recent advances with novel mouse models and research
tools to overcome prior research barriers and bolster our human experimentation. Importantly, to achieve its
goals, this grant builds on ample preliminary data and the highly complementary expertise of its investigators
to ensure feasibility and scientific rigor. This study’s findings have potential to profoundly impact fundamental
understanding of not only antibiotic-induced dtDHR but more broadly allergy and immunology in health and
disease, while also to directly transform clinical care in both the short- and long-term.

Public health relevance
Project Narrative Antibiotic-induced delayed-type drug hypersensitivity reactions (dtDHR) are a major yet understudied public health problem. This transformative study uses a comprehensive and unbiased prospective longitudinal study along with highly innovative translational laboratory approaches to investigate disease pathogenesis. This work has potential to dramatically shift current avenues of research as well as clinical care.